Core A: Administration

Core A: Abstract
Administrative Core. This administrative Core will have both scientific and organizational responsibilities. The
scientific aspects will be carried out by Dr. Kwiatkowski. He will advise investigators on strategic and technical
issues, promote collaboration and contact among projects, monitor the functions and effectiveness of the core
facilities, and assess the scientific quality and progress of the work. This will require active interactions with all
investigators on a regular basis. Any scientific problems or organizational issues that arise will be discussed
with the co-PI, Dr. Henske. There will be regular meetings with presentations by each PI, and an annual all-day
meeting at which Project and Core Investigators will present research progress at a symposium organized
jointly with the DFHCC. Organizational aspects of the PPG will be handled by Dr. Kwiatkowski and the
Administrative Coordinator, Mrs. Karen Forti. She will organize all interactions among the projects and the
cores, including arranging the annual meeting, and deal with all other administrative aspects including
preparations of all progress reports and applications related to this PPG.

Public health relevance
Core A: Narrative The overall goal of this program project application is to find treatments for the hamartoma syndromes, and the common cancers in which these same genes (TSC1, TSC2, LKB1, PTEN) are involved. This administrative core serves a critical function in the administration and facilitation of this overall research program.